EFFECT OF IMPROVING CAREGIVING ON EARLY MENTAL HEALTH

The intent of this project is to experimentally improve the stability and consistency of caregiving staff and to train them to be more socially responsive and developmentally appropriate in a St. Petersburg, Russia, baby home for children birth to 4 years, and to observe the consequences of such improved caregiving on early mental health, including the physical development, mental/developmental and social-emotional growth of the children who are adopted into the U.S.A. The development of children within the intervention baby home will be compared with baseline information, a baby home receiving training but no staffing changes, and a baby home receiving no intervention. Longer-term progress of children adopted into the USA will be compared with non-treated children from the same homes, adopted children from other St. Petersburg baby homes, home-reared American children, and perhaps unselected foreign adopted children in Minnesota.